A Fluorescence-Based High-Throughput Platform for Glycotyping the Hematopoietic Cell Lineage

PIs: Buelow – Steidl Project Summary The surface characteristics of cells in multicellular organisms are a direct reflection of their function. Sensitive methods for detecting and defining novel surface characteristics of cells offer great opportunities for gaining new mechanistic insights and developing new therapeutic strategies. Heparan sulfate (HS) glycans are ubiquitous on the cell surface of metazoans and are expressed with extraordinary temporal and spatial resolution. Since HS are amongst the most diverse molecules in nature, as a result of complex modification patterns of the glycans, they could potentially provide the means to strongly discriminate between different cell and tissue types. However, current analytical methods for HS glycan structure determination are expensive, technically challenging and often low resolution, limiting their discriminatory power and widespread use. The development of novel tools to define and exploit the structural characteristics of HS on the surface of cells could open new avenues with important diagnostic and, possibly, therapeutic potential. We will develop a high- throughput, multiplexed fluorescence-based platform to define the HS surface characteristics using a set of HS-specific single chain variable fragment (scFvs) antibodies. We will first engineer the set of HS-specific single-chain variable fragment antibodies with various immunotags as well as directly label them with fluorescent tags using Sortase based approaches. Next, we will systematically determine the HS motifs that are recognized by the scFv antibodies using a combination of microarrays with defined heparan sulfate oligosaccharides and novel computational tools, which we will develop to define the HS motifs recognized by these reagents. Finally, in proof of principle experiments, we will apply our tool box of immuno reagents against defined HS motifs as an orthogonal system to the well-established cluster of differentiation (CD) system to characterize and define hematopoietic cell lineages. We will leverage our laboratories' unique capabilities in protein production and hematopoiesis research to generate, test, and disseminate the fluorescently labeled scFvs reagents and protocols to the research community. We anticipate that our robust, efficient and economical assays will lead to more widespread and standardized analyses of HS characteristics, which will lay the foundation for the development of novel diagnostic and therapeutic approaches in the blood and other systems in the future.

Public health relevance
PIs: Buelow – Steidl Project Relevance Cell surface glycans, such as the molecularly highly diverse heparan sulfates govern cell adhesion, motility, proliferation and survival during development, normal physiology and various diseases including malignancies. Heparan sulfate have great potential as biomarkers, yet their detailed characterization remains incomplete due to the lack of sufficiently robust tools and strategies. To address these road blocks, we are developing a simple, accessible and easily transportable tool box of immuno reagents to differentiate cells based on their heparan sulfate glycan characteristics. We will establish the glycan motifs that are recognized by these immuno reagents and establish them as a novel and efficient, orthogonal cell marker system for the blood cell lineage. This approach offers significant diagnostic enhancements relative to existing techniques and could support the development of novel diagnostic and, ultimately, therapeutic approaches.